Functional Analyses of Antiviral CD4+ T Cell Responses

Protective immunity, whether induced by infection or by vaccination, relies on the generation of memory B & T cells in sufficient quantity, and of sufficient quality. The success of this process is heavily dependent on help that is provided by CD4+ T cells. CD4+ T cells play a central role in orchestrating the adaptive the immune response but the mechanism by which their abundance is regulated, the importance of recurrent antigen contact, and the means by which they provide help to CD8+ T cells all remain uncertain. The overall goals of this application are (i) to continue our studies of how CD4+ T cell quantity and quality are regulated in vivo by IFNγ, and how they are affected by in vivo contact with persistent virus antigen (Aims 1 & 2); and (ii) to investigate how CD4+ T cells provide the help that is required for the development of good antiviral CD8+ T cell memory (Aims 3 & 4). Aim 1. To determine how direct IFNγ signaling exerts its profound effects on the abundance of primary and memory CD4+ T cells. We have shown that CD4+ T cells that can respond directly to IFNγ are 100- fold more abundant in the memory pool. We will determine when the effect of IFNγ is exerted; what changes in gene expression occur as a result; and which cells produce this important cytokine. Aim 2. To evaluate the effects of prolonged MHC class II antigen presentation on CD4+ T cell quantity and quality. It is well-established that, during chronic infection, persistent antigen can dramatically alter the T cell response. However, the issue of antigen persistence is much less well-defined in models of acute viral infection. We have found that MHC class II presents virus antigen for weeks after acute virus infection. We shall measure the effects of persistent antigen on CD4+ T cell functions. Does antigen- driven IFNγ production sculpt the CD4+ T cell response? Aim 3. To investigate the help that is provided by virus-specific and non-specific CD4+ T cells. My lab was among the first to show that CD4+ T cells played a key role in establishing CD8+ T cell memory following acute virus infection, an observation that has been confirmed and extended by a number of labs. Surprisingly, CD4+ T cells seem to be able to provide help to CD8+ T cells in a non-specific (noncognate) fashion. We shall compare the helpfulness of CD4+ T cells that are specific for a viral epitope, with the helpfulness of CD4+ T cells that cannot recognize the virus. Aim 4. To determine if IFNγ is a key mediator of CD4+ T cell help. The final Aim draws together two threads: (i) the fact that CD4+ T cell help is required for the development of good CD8+ T cell memory and (ii) our recent finding that IFNγ is vitally important for the development of CD8+ T cell memory. Might IFNγ be the link by which CD4+ T cells help the development of CD8+ T cell memory? Is the role of IFNγ the same for specific & non-specific CD4+ helper T cells?

Public health relevance
CD4+ T cells play a central role in regulating the immune response to infection and vaccination. Surprisingly, we do not know exactly what they do, and how they do it. Indeed, some recent data suggest that vaccines might work quite well even if the do not stimulate CD4+ T cell responses. This grant application investigates several of the questions surrounding the important, but poorly-understood, cells.